Untargeted Analysis Resource

SUMMARY UNTARGETED RESOURCE
The Untargeted Analysis Resource is a multi-disciplinary exposomic program designed to integrate
environmental measures and biological response into existing NIH studies. We hold weekly Steering
Committee meetings of the full Lab Hub team to discuss jobs, troubleshoot workflows, and prioritize resources
and activities in order to provide state-of-the-art service to HHEAR clients. Our team has considerable
expertise in matching the underlying systems biology of untargeted exposure biomarkers to the study design
and health phenotypes, with a range the biological specimen types that would be typically available in health
studies. We also factor in subject age, occupation and the likely exposure scenarios. Our lab feasibility
assessments help shape the science of a client's submission towards higher impact studies. We also counsel
clients on preventing the wasting of precious samples on assays they may request, but which are deemed
likely to be of limited values based on our many years of research experience and understanding of exposure
scenarios. We work with the Administrative Core to coordinate services, including sample management,
receiving, labeling and tracking. We serve as expert consultants with the Coordinating Center, PI/Clients and
other HHEAR Resources. We collaborate with the Data Center in the management of results reporting,
ensuring that data are properly formatted and have sufficient metadata, as well as participate in the analysis of
exposure/phenotype relationships. We use automated sample handling and preparation methods and high
throughput analytical procedures and rigorous inter-laboratory QA/QC procedures which include real time
analysis monitoring and database management through state-of-the-art laboratory information management
software, as well as automated data processing to reduce human error. Our methods ensure proper sample
tracking and data reporting and avoid mismatches of samples to results. With substantial institutional
resources at its disposal, the Untargeted Resource has doubled the number of mass spectrometry instruments
to 14 in the last 3 years, ensuring our capacity to serve the needs of the HHEAR Network. Our team also
conducts extensive outreach and was the only CHEAR lab hub to organize a National Exposome Symposium
(held Nov 2-3, 2018 at Mount Sinai and themed on Exposomics) as described in the Administrative Core.
QA/QC protocols and standard operating procedures for all target compounds have been established to
maintain the quality of the chemical analysis. We participated in all CHEAR mandated QA/QC and PT
programs including the round-robin analysis of a pooled urine sample between all Untargeted CHEAR Labs,
and will do so for HHEAR. Overall, we process and analyze samples with a high degree of efficiency and
accuracy, provide expert scientific consultation and integrate our work with the other Hub components while
maintaining the highest standards of productivity and cost-effectiveness.